The transcription factor RUNX1 is pivotal in TGFβ-activated cholangiocyte signaling with the immune system in biliary fibrosis

PROJECT SUMMARY/ABSTRACT
Primary sclerosing cholangitis (PSC) and primary biliary cholangitis are characterized by biliary fibrosis, which
involves activated cholangiocyte signaling with immune cells. Insufficient understanding of the transcriptomic
and lipidomic changes in activated cholangiocytes that orchestrate signaling with the immune cells is a major
barrier for developing effective therapies for biliary fibrosis. Transforming growth factor-β (TGFβ), a key mediator
of fibrosis, activates cholangiocytes to produce fibroinflammatory signals. Our preliminary data show that Runt-
related transcription factor 1 (RUNX1) expression is increased in models of biliary fibrosis and PSC livers.
RUNX1 inhibition reduces the upregulation of fibroinflammatory signals in TGFβ-activated and PSC-derived
cholangiocytes. RUNX1 inhibition in a mouse model of biliary fibrosis reduces the hepatic peri-portal infiltration
of immune cells and markers of hepatic injury. The effects of RUNX1 may be further facilitated by its upregulation
of stearoyl-CoA desaturase-1 (SCD1) and lipid signaling. Treatment with an SCD1 inhibitor, Aramchol – an agent
with a well-established safety profile in clinical trials – results in reduced fibroinflammatory markers in mouse
models of biliary fibrosis. Therefore, we hypothesize that RUNX1 plays a crucial role in the activation of
cholangiocytes by coordinating an interdependent transcriptomic and lipidomic program that stimulates
immune cells. To test this novel hypothesis, we propose two specific aims. In aim 1, we will investigate RUNX1
co-regulators of gene expression and the full spectrum of RUNX1-dependent fibroinflammatory pathways in
TGFβ-activated cholangiocytes. Using a biliary epithelial-specific Cre, we have generated cholangiocyte-
selective Runx1 genetic deletion to study immune cell recruitment and activation, and fibrosis in mouse models
of biliary fibrosis. We will also determine the direct effects of cholangiocyte RUNX1-induced signals on
macrophage activation and Th17 cell differentiation using in vitro co-culturing of primary cells and spatial
transcriptomic and single cell RNA-seq analyses of PSC and mouse model livers. In aim 2, we will determine if
TGFβ-RUNX1 signaling directly regulates SCD1 expression and function, and effects on cholangiocyte
fibroinflammatory lipidomics. The effects of SCD1 on cholangiocyte lipidomics and fibroinflammatory signals will
be investigated in mouse models of biliary fibrosis using Aramchol and Scd1 genetic deletion. TGFβ-induced
transcriptomic and lipidomic changes in cholangiocytes will be integrated to better define the roles of RUNX1
and SCD1. Further elucidation of these transcriptomic and lipidomic regulatory mechanisms will advance our
grasp of biliary fibrosis and support the development of effective therapies. Therefore, our proposal is consistent
with the objectives of NIDDK in understanding and developing therapeutic avenues for hepatobiliary diseases.
Additionally, this proposal will allow a promising physician-scientist to gain expertise in the epithelial immunology,
lipidomics, and transcriptomics of biliary fibrosis under the expert guidance of highly dedicated mentors to
successfully transition to an independently funded physician-scientist with a unique research program.

Public health relevance
PROJECT NARRATIVE In diseases such as primary sclerosing cholangitis and primary biliary cholangitis, biliary fibrosis is the predominant pathological process, involving signaling among activated bile duct cholangiocytes, immune cells and fibrosis-producing myofibroblasts. Transforming growth factor-β (TGFβ), a key signaling factor for fibrosis, activates cholangiocytes to produce immune and myofibroblast-activating cytokines, which likely requires the Runt-related transcription factor 1 (RUNX1). The focus of this application is to examine the mechanistic role of RUNX1 in the TGFβ-stimulated fibroinflammatory effects and to identify cellular/molecular targets for developing novel therapeutic strategies for biliary fibrosis.